Delivery of Addiction Treatment for Medicaid Enrollees with Serious Injection-Related Infections

PROJECT ABSTRACT:
Rising rates of injection drug use in the United States have led to a crisis of serious injection-related infections
(SIRI) affecting people who inject drugs (PWID), such as endocarditis, osteomyelitis, and spinal abscess. SIRI
are associated with high severity and mortality, often needing long hospitalizations, and need for intensive
health services. Addiction treatment interventions, such as addiction specialty consultation or initiation of
medications for opioid use disorder, have shown benefit in smaller studies and in commercially insured
populations. Evidence generated in Medicaid populations is needed to inform Medicaid program policies. In
this proposal, our overall objective is to comprehensively understand addiction treatment delivery for patients
with SIRI, including variation and disparities in treatment intervention delivery, and the associations of those
interventions with clinical and economic outcomes. Specifically, we aim to 1) Use national Medicaid
administrative data from 2015-21 to determine if delivery of addiction treatment interventions to PWID
hospitalized with SIRI is associated with clinical and economic outcomes, 2) how hospital- and area-level
capacity to provide addiction treatment explains the variation in treatment delivery, and 3) use qualitative
methods to determine the factors that promote or hinder addiction treatment interventions in hospital settings.
To improve outcomes for PWID with SIRI, we first need to understand the current landscape of healthcare
delivery, and the motivating factors that will transform healthcare practices to better meet the needs of PWID.
Understanding the gaps in evidence-based healthcare delivery for SIRI in the United States are critical first
steps for implementing system change to improve care for PWID with SIRI.

Public health relevance
PROJECT NARRATIVE People who inject drugs are susceptible to being hospitalized with severe bacterial and fungal infections but may not receive evidence-based treatment for substance use disorder in the hospital. Using national Medicaid data and qualitative methods, we will study how addiction treatments are delivered to people hospitalized with injection-related infections, how those treatments are related to clinical outcomes, and how to improve the addiction-related healthcare for this population.